Standard versus High Dose ED-Initiated Buprenorphine Induction

Abstract
Drug overdoses in the U.S. increased to over 107,000 in the year ending January 2022 including > 80,000
involving opioids, representing a 24% increase from the prior year. Despite improved outcomes and decreased
all-cause mortality among individuals with opioid use disorder (OUD) who receive opioid agonist treatment,
only 11% of individuals with OUD receive medications for opioid use disorder. Narrowing the treatment gap by
expanding access to treatment beyond specialized drug treatment settings is a public health priority, and the
Emergency Department (ED), offering access 24 hours, 7 days a week, 365 days a year, is a logical point of
intervention. ED patients have a disproportionately high prevalence of OUD, and for many, the ED is the
primary or only access point in the healthcare system. There are currently no controlled, prospective studies
comparing dosing strategies for buprenorphine induction in the ED. We
propose
a
multisite randomized
double-blind, double-dummy, clinical trial of ED patients with moderate to severe OUD (N=360) from 4
geographically diverse EDs to compare Standard ED Dose Induction (SDI; 8 mg) with High Dose Induction
(HDI; 24 mg) to evaluate AIM 1: Engagement in continuing OUD treatment at 10 days and AIM 2: Differences
in outcomes of craving, tolerability, withdrawal symptoms, and use of illicit drugs. We hypothesize that patients
assigned to the HDI group will be more likely to be engaged in OUD treatment at 10 days post ED enrollment
(primary outcome), and will describe less craving, less withdrawal symptoms and less use of illicit drugs during
the 10 days post ED buprenorphine induction. Additional outcomes will be the development of ED protocols,
and evaluation of safety, feasibility, and acceptability. The primary outcome of engagement in treatment at 10
days as well as treatment at day 30 will be verified by the treating clinician. Assessment of craving, withdrawal
symptoms and use of illicit drugs will be obtained by daily Qualtrics phone surveys. The planned study sample
and the proposed analytical methods will allow for additional meaningful exploratory evaluations of potential
differential effects of gender, race, ethnicity, housing instability, insurance status, and use of fentanyl, and
other polysubstance use such as stimulants, sedatives, and alcohol. An accelerated
achieves
potentially
treatment
induction process that
therapeutic buprenorphine levels in less than 3-4 hours compared to the typical 2-3 days could
increase safety during the crucial gap between ED discharge and engagement in continuation
by limiting illicit opioid use and encouraging follow up visits for OUD treatment.

Public health relevance
Project The and standard addiction Narrative emergency department (ED) provides an opportunity to care for patients with opioid use disorder (OUD) initiate treatment 24 hours, 365 days a year. This project will test two dosing strategies of buprenorphine, ED dosing versus a high dose accelerated induction process, in engaging patients with ongoing treatment while evaluating treatment engagement, craving, withdrawal symptoms and use of illicit drugs.